PheBC: bias correction methods for EHR derived phenotype

Project Summary
In response to the (PAR-18-896), the overarching goal of this proposal is to fully develop
a joint effort between statisticians, medical informaticians, clinicians with a focus on developing
a rigorous bias correction framework through modern knowledge engineering and data-driven
statistical modeling, for improving the unbiasedness and reproducibility of health system data
driven research.
In this proposal, we will focus on: (1) Develop a novel prior-knowledge-guided integrated
likelihood approach to enable bias correction by incorporating prior phenotyping accuracy. (2)
Develop methods and algorithms to account for EHR phenotyping errors in both outcomes and
predictors. And (3) Validation, Application and Software development. We will use the proposed
bias correction methods to several EHR datasets to replicate existing findings and investigate
new hypothesis in multiple datasets at University of Texas and University of Pennsylvania. We
will also develop software for the proposed methods to facilitate ongoing EHR-based clinical
studies.

Public health relevance
Project Narrative Data derived from electronic health records (EHR) provide tremendous opportunities for clinical and translational research. A key challenge remains that the reproducibility of findings across studies is limited, which raised a fundamental concern on the value of these researching findings. The overarching goal of this proposal is to develop a rigorous bias correction tool through modern knowledge engineering and data-driven statistical modeling, for enhancing the reproducibility of EHR-based clinical findings.